Massachusetts Center for Birth Defects Research and Prevention: Birth Defects Study To Evaluate Pregnancy exposureS (BD STEPS Core and Stillbirth)

Project Summary / Abstract
The Massachusetts (MA) Center for Birth Defects Research and Prevention (MCBDRP) proposes to continue
its strong track record of conducting etiologic research to identify modifiable risk factors for structural birth
defects through its participation in the Birth Defects Study to Evaluate Pregnancy exposureS (BD-STEPS). We
will enhance our contributions by leveraging our longstanding relationship with local universities to produce
future birth defects researchers. The MCBDRP brings to BD-STEPS our expertise and leadership in
pharmacoepidemiology and collaborative utilization of unique data resources to be applied to all three key
areas of interest named in the Notice of Funding Opportunity. Our research will utilize existing data from the
National Birth Defects Prevention Study and BD-STEPS, as well as data collected in the next iteration of BD-
STEPS. The MCBDRP investigators are committed and successful mentors and collaborative partners, roles
that will continue and expand within BD-STEPS. Over the three and a half year grant period, the MCBDRP will
complete at least seven etiologic research projects of public health significance that will aid in counseling
women in considering exposures that are less likely to result in a birth defect; these projects include: 1)
Assessing anti-obesity medications that have been and will continue to be approved by FDA and assessing
bariatric surgical procedures that are increasingly performed which may lead to beneficial weight loss, though it
is uncertain how potential nutritional deficiencies may impact subsequent pregnancies; 2) Investigating
attention deficit hyperactivity disorder medications, the use of which has increased dramatically; 3) Evaluating
nicotinamide adenine dinucleotide pathway inhibitors and the potential preventive effect of supplementation
with niacin; 4) Evaluating medication use during pregnancy by severity classifications of congenital anomalies;
5) Gauging the complex relationship among multiple risk factors to further our understanding of birth defects; 6)
Examining anti-viral medications, which are key to preventing maternal-fetal transmission but for which little is
known about their safety with respect to birth defects; and 7) Leveraging the MA State Public Health
Laboratory’s reportable disease database to explore the role of infections before and during pregnancy on the
development of birth defects. Through these activities, the MCBDRP will be an essential partner in BD-STEPS
to achieve our overall goal of translating research findings into meaningful initiatives in birth defects prevention.

Public health relevance
Project Narrative The activities and projects proposed in this application are designed to test or generate specific hypotheses of considerable etiologic importance, with the ultimate goal of informing clinical and public health prevention messages and interventions to reduce the occurrence of birth defects. The vast majority of pregnant women take medications, yet in regard to risks of birth defects, we know little about the safety of most of these medicines; given this critical knowledge gap, many of our proposed projects focus on detailed analyses of maternal illnesses and medications as risk factors for birth defects. We will employ novel approaches such as assessing medications by their mode of action and discerning if increased risks are due to the underlying infection, its treatment, or both.